Top Down Regulation of Feeding-related Behavior

PROJECT SUMMARY
Obesity is one of the greatest public health concerns facing our country. The condition is
linked to deficits in specific domains of cognitive function, namely working memory and behavior
inhibition, which can affect food seeking and food intake behavior. Melanocortin peptides in the
hypothalamus and their central nervous system-based receptors, such as the melanocortin 4
receptor (MC4R) play a role in obesity pathophysiology, as well as hyperphagia.
Our preliminary data suggest a novel circuit linking arcuate hypothalamic neurons to
MC4R-expressing neurons in the medial prefrontal cortex (mPFC). The mPFC is a region of the
brain involved in goal-oriented and habit-based behavior, as well as the integration of external
and internal cues. It is made up of discrete subregions that work together to coordinate
behavior. Inputs to this region from the hypothalamic metabolism neurons that provide food or
body-state-related information would likely be critical for effective feeding decisions, such as
stopping eating when full, that could directly influence long term body weight gain. We propose
that this melanocortin-based circuit relays food-related information that influences neuronal
dynamics in the subregions of the mPFC and also regulates food intake to effect body weight.
We hypothesize that this circuit specifically affects cognitive behavior associated with
hyperphagia, impairing feeding and energy expenditure, which we will test using a number of
complementary cutting-edge approaches in mice.
First, we will define the connectivity between the two subpopulations of hypothalamus
melanocortin peptide expressing neurons and the MC4R-expressing neurons in the subregions
of the mPFC (Aim 1). Next, we determine the necessity of the melanocortin 4 receptor (MC4R)
in each of the subregions of the mPFC in obesity-related physiology, food intake, and cognitive
behavior (Aim 2). Finally, we will demonstrate the functional effects of the putative circuit in
feeding, metabolism, and cognitive behavior (Aim 3). All studies will be done in male and female
mice due to known sexually dimorphic properties within the mPFC subregions and MC4R.
The proposed studies seek to demonstrate a functional circuit between the
melanocortinergic hypothalamic neurons and the mPFC subregion MC4R-expressing neurons
that is at least partly responsible for pathogenesis and hyperphagia in obesity. Results from
these studies will identify critical targets linking feeding behavior, cognitive function, and obesity,
and provide new avenues for novel treatment.

Public health relevance
PROJECT NARRATIVE Obesity negatively impacts the quality of life and lifespan for millions of people in the US, and is commonly associated with deficits in cognitive functions. Cognitive function is regulated by subregions of the medial prefrontal cortex, and these subregions are play different roles in obesity-associated behaviors that can affect food intake and body weight. In this study, we will use transgenic mouse models and cutting-edge neuroscience techniques to probe metabolic melanocortin circuitry from the hypothalamus to the subregions of the prefrontal cortex to define new circuit-based mechanisms and treatment opportunities for obesity.